Gene-tobacco carcinogen interactions and lung cancer risk - a novel approach for precision cancer prevention

The tobacco-specific nitrosamine (TSNA), 4-(methylnitrosamino)-1-(3-pyridyl)-1-butanone (NNK), is considered
a major contributor to the induction of lung cancer in smokers. The metabolism of NNK is complex with its
carcinogenic effects likely via the formation of its major pro-carcinogenic metabolite, 4-(methylnitrosamino)-1-
(3-pyridyl)-1-butanol (NNAL). Two enantiomers of NNAL are formed: (R)- and (S)-NNAL, both of which are
extensively detoxified by glucuronidation in humans. Our novel preliminary data demonstrate a strong and
statistically significant inverse association between the ratio of urinary (R)-NNAL-glucuronide (Gluc)/(S)-NNAL-
Gluc and lung cancer risk in two independent prospective cohort studies. Furthermore, smokers homozygous
for the deletion polymorphism of the major NNAL-glucuronidating enzyme, UGT2B17, had a significant 3-fold
higher risk for lung cancer than those with at least one functional UGT2B17 allele in both cohorts. These data
strongly support our hypothesis that (R)-NNAL plays a key role in tobacco-induced lung carcinogenesis and
suggests that we have identified novel important phenotypic and genetic markers of lung cancer risk. The goal
of this proposal is to evaluate the importance of NNAL enantiomers and glucuronides in lung cancer
carcinogenesis, and to elucidate novel phenotypic and genetic markers of NNAL formation and elimination
pathways and lung cancer risk in multiple populations. Our goals are to prospectively evaluate whether the
levels or ratios of specific urinary NNAL isomers or glucuronides are associated with lung cancer risk in: (1)
Chinese smokers from three cohort studies from Shanghai and Singapore, and (2) White and Black smokers
from the Southern Community Cohort Study, and to subsequently screen and validate genetic variants
associated with the variability in NNAL enantiomer and glucuronide formation. These studies should provide
crucial insight for understanding variability and establishing phenotypes and genotypes important in lung
cancer risk and will assist in identifying smokers at high risk for lung cancer for the development of
chemopreventive strategies targeting the NNK metabolism pathway.

Public health relevance
Project Narrative The major mode of metabolism of NNK, a major contributor to the induction of lung cancer in smokers, is via the formation of its pro-carcinogenic metabolite, NNAL. Two enantiomers of NNAL are formed -- (R)-NNAL and (S)-NNAL, with (R)-NNAL the major isoform formed in the lung and both enantiomers detoxified by glucuronidation. We provide novel preliminary data demonstrating a strong and statistically significant inverse association between the ratio of urinary (R)-NNAL-glucuronide (Gluc)/(S)-NNAL-Gluc and lung cancer risk in smokers from two independent large cohort studies, and this novel, stable biomarker of lung cancer risk reflects the potential importance of (R)-NNAL in the carcinogenicity of NNK and strongly supports the goals of this proposal which is to evaluate the importance of different NNAL enantiomers and glucuronides in lung cancer carcinogenesis and to elucidate novel urinary biomarkers of lung cancer risk focusing on the NNAL formation and elimination pathways.